Promotion of satellite cell proliferation by cAMP signaling

SUMMARY

Skeletal muscle regeneration requires activation and proliferation of a resident population of stem cells known
as satellite cells. Satellite cells are not only required for muscle regeneration after injury but are also thought to
contribute to ongoing maintenance of muscle mass. Unfortunately, the number and activity of these progenitors
declines with aging and muscular dystrophy. Therefore, pharmacologic strategies to promote expansion of
myogenic satellite cells could potentially be used to improve muscle regeneration and preserve muscle function
in individuals with muscle disease or individuals of advanced age. Signaling through the cAMP pathway
stimulates myogenic progenitor cell proliferation during embryonic development and is sufficient to stimulate
proliferation of these cells in vitro. This pathway is also activated during regeneration in adult mice. However, it
is unknown whether cAMP signaling in myogenic progenitor cells in response to injury is sufficient to enhance
proliferation in vivo. We previously showed that the cAMP-­responsive transcription factor CREB is activated in
areas of proliferation after acute muscle injury in mice and that mice expressing an activated mutant of CREB
have enhanced myoblast proliferation after injury. This project employs biochemical and chemical-­genetic tools
to determine whether chemical-­genetic elevation and genetic regulation of cAMP signaling specifically in satellite
cells alters proliferation and muscle regeneration in vivo through regulation of CREB/CRTC transcriptional
complexes. We will interrogate the regulation and function of cAMP-­regulated CREB co-­activators (CRTCs) in
satellite cell proliferation and use unbiased transcriptomic approaches to identify CREB/CRTC target genes that
contribute to the cAMP-­driven proliferative response. We will undertake mechanistic studies to characterize
molecular regulation of CRTCs and the mechanism of CRTC recruitment to cAMP-­regulated genes in
proliferating satellite cells. Results of this project will yield insights into fundamental mechanisms that drive
satellite cell proliferation and expansion. The long-­term goal is to identify new pharmacologic targets to improve
muscle regeneration and function in patients with muscle disease and age-­related sarcopenia.

Public health relevance
NARRATIVE The proposed studies will investigate cellular signaling pathways that regulate skeletal muscle stem cell proliferation. Loss of skeletal muscle stem cell capacity is associated with aging and degenerative muscle disease. Identification of the signaling pathways and genes that stimulate muscle stem cell proliferation could reveal new ways to help maintain muscle health and function during aging.